Extracellular Vesicles for Gaining Insights into Tissue Senescent Signatures: A SenNET Pilot and Exploratory Project

Abstract
This Administrative Supplement to KAPP-Sen Tissue Mapping Center (TMC) award (U54AG075941)
funded by National Institute of Aging to leverage recent advances in the development of technologies
used for the detection of senescence markers within tissue-speciﬁc extracellular vesicles (EVs). The
PA-20-272 (Administrative Supplements to Existing NIH Grants and Cooperative Agreements) notes
that this funding mechanism be used to cover cost increases that are associated with achieving
certain new research objectives, as long as the research objectives are within the original scope of
the peer-reviewed and approved project. Speciﬁc Aims of U54AG075941 include Aim 1: Coordinate
research activities across KAPP-Sen TMC Collaborative sites in support of Sen-Net goals towards
mapping cellular senescence and its associated secretory phenotype in the healthy human kidney,
adipose tissues, pancreas and placenta. Aim 2: Obtain tissues from healthy kidney transplant
donors (kidneys, fat, skin), C-section pregnancies (placenta, cord, fat, skin), outpatient healthy
donor biopsies (fat, skin), beating heart brain dead donors (full pancreas) and IIPD/Prodo (dispersed
pancreas). Aim 3: Generate highest-quality data pertaining to cellular senescence including scRNA-
Seq, snRNA-Seq, spatial transcriptomics, immunohistochemistry and Telomere-associated DDR
foci (TAFs) in all tissues. Aim 4: Perform high-level integrative data analysis required for the creation
of aUases of human cellular senescence in collaboration with other TMCs, CODDC and NIH staff.
Our Administrative Supplement proposal seeks to leverage ongoing work conducted by our KAPP-
Sen TMC to create maps of senescent cells in Kidneys, Adipose tissues, Pancreas, and Placenta
with advances involving new techniques designed to isolate, identify, characterize, and quantify
tissue-speciﬁc EVs from blood and urine, combined with senescent biomarkers.
Our Overarching Hypothesis raises the rather intriguing possibility that EV subsets and their protein
cargo components may function as a liquid biopsy, thus permitting the non-invasive qualitative and
quantitative evaluation of the senescent cell burden residing within the tissues from which those EVs
likely originate. Furthermore, suppose future evidence was to support this postulate. In that case,
such a development might permit clinicians to one day link peripheral blood- or urine- borne EV
biomarker data to information residing in curated high-resolution senescent cell data obtained via
SenNET.

Public health relevance
Project Narrative – Administrative Supplement KAPP-Sen Tissue Mapping Center is dedicated to developing high-quality maps of senescent cells in kidney, adipose, pancreas, and placenta tissues from healthy adults. The goal of this administrative supplement is to collect blood and urine samples from these participants, developing noninvasive markers of senescent cells that do not require tissue biopsies. This will be accomplished by collecting, isolating, and studying extracellular vesicles, which are components found in blood and urine.